Parsing Mechanistic Relationships Between Circuits and Negative Valence System Behaviors in Treatment-Resistant Depression with Ultrasound Neuromodulation

PROJECT SUMMARY
Approximately one third of individuals with depression are considered treatment-resistant (TRD) and exhibit
symptoms anchored in abnormalities of RDoC Negative Valence Systems behavioral processes. For example,
anhedonia and rumination contribute to significant impairment in daily functioning, high relapse rates, and a
staggering global toll of over 700,000 annual suicides. One reason for inadequate treatment response is our
limited understanding of causal mechanisms linking brain circuit function to Negative Valence behavior abnor-
malities, which impedes the development of precision neuromodulation treatments. We propose to address this
problem by using low-intensity focused ultrasound (LIFU), which can noninvasively and reversibly modulate
deep brain circuits, to determine the mechanistic relationship between cortico-subcortical circuits and distinct
Negative Valence System behaviors including reward processes and rumination. Substantial preliminary evi-
dence suggests that aberrant connectivity between the thalamus and orbitofrontal (OFC) or anterior cingulate
(ACC) cortices in the right hemisphere contribute to distinct depression-related RDoC Negative Valence sys-
tem behavioral changes. In a preliminary clinical trial, which received a non-significant risk determination by the
FDA (NCT05697172) we observed safe modulation of deep white matter tracts using LIFU. We now propose to
employ advanced structural imaging techniques to tailor modulation targets to each patient's unique anatomy.
Our study will involve 120 TRD participants who will receive LIFU and sham stimulation to individually-defined
white matter tracts connecting thalamus with either OFC (n=60) or ACC (n=60). We will measure resting-state
functional magnetic resonance imaging (fMRI) changes, and changes in two behavioral models underlying
Negative Valence manifestations (monetary incentive delay and induced rumination tasks). Our hypothesis is
that thalamo-OFC and thalamo-ACC hyperconnectivity, historically targeted in neuromodulation techniques
useful in TRD, contributes to distortions in distinct behavioral components of the Negative Valence system.
This proposal thus has the following Specific Aims: In Aim 1, we will determine the anatomical specificity of
LIFU when applied to thalamo-OFC and thalamo-ACC white matter tracts. We predict that LIFU will lead to re-
duced functional connectivity in the specific cortical regions reached by the modulated white matter bundles. In
Aim 2, we will correlate connectivity between thalamus and OFC or ACC, with functional features of distinct
behaviors pertaining to the RDoC Negative Valence. Exploratory Aim 3 will establish behavioral correlates of
such neural changes. If successful, the present proposal will contribute to understanding clinically meaningful
brain-behavior mechanistic relationships by parsing thalamo-prefrontal circuits and RDoC Negative Valence
system behaviors. In turn, such definition of targets with a causal role in abnormal behavior processes, could
inform precision therapeutic neuromodulation in a psychiatric population in utter need of innovative treatments.
1

Public health relevance
PROJECT NARRATIVE Approximately one third of individuals with Major Depressive Disorder (MDD) are considered treatment-re- sistant, subject to severe disability and risk of suicide, and exhibit symptoms anchored in abnormalities of RDoC Negative Valence Systems behavioral processes. In the present study we plan to use low-intensity fo- cused ultrasound in 120 persons with treatment-resistant MDD to modulate deep white matter tracts connect- ing the thalamus and different regions of the prefrontal cortex reversibly and noninvasively, with the aim of as- signing a causal, mechanistic role to large scale brain circuits in the production of those critical behavioral ab- normalities. A successful study will help to attain the precise definition of neuromodulation targets for this clini- cal population in utter need of help. 1